Molecular Regulation of Cardiovascular 7 TM Receptors

? DESCRIPTION (provided by applicant): All aspects of cardiovascular function are regulated by receptors of the seven transmembrane receptor (7TMR or GPCR) families, and they are the commonest target of therapeutic drugs. A universal mechanism regulating these receptors is desensitization of heterotrimeric G protein signaling. Classically, this is mediated by a two- step process in which activated receptors are phosphorylated by G protein-coupled receptor kinases, leading to the binding of a ß-arrestin (ßarr) molecule which sterically interdicts further activaion of the G protein. More recently it has become clear that ßarrs can also serve as multifunctional adaptors which act as signal transducers in their own right. Moreover, many receptors ligands can be found which disproportionately activate either G protein- or ßarr-mediated signaling - i.e. biased ligands which may possess greater specificity of action and fewer side effects. One such ligand for the angiotensin II type 1 receptor (AT1R) is now in clinical trials for decompensated congestive heart failure. Accordingly this proposal has three closely linked aims which involve developing a molecular- and atomic-level understanding of how such ßarr-mediated signaling is generated using as model systems two receptors of great cardiovascular significance, the ß2- adrenergic receptor and the AT1R. 1) To determine the molecular mechanisms underlying biased agonism at the AT1R utilizing a remarkable panel of both G- and ßarr-biased AT1R peptide ligands which we have previously characterized. The dynamic biophysical techniques of electron paramagnetic resonance and hydrogen deuterium exchange mass spectrometry will be utilized to reveal the nature of the biased receptor conformations. 2) To determine the molecular mechanisms underlying 7TMR-ßarr interactions by applying these same techniques to complexes of these two receptors with ßarr, obtaining information on both receptor and ßarr conformations. 3) To crystallize and determine the structures of these 7TMR-ßarr complexes. The insights which we will generate have the potential to guide the design of powerful new cardiovascular drugs and will further our understanding of the conserved signaling mechanisms of the greater 7TMR family.

Public health relevance
PUBLIC HEALTH RELEVANCE: Some of the most important drugs used to treat cardiovascular disease such as "ß blockers" (ß-adrenergic receptor antagonists) and "ARBs" (angiotensin receptor blockers) target specific receptors on the outside of cells. Here we seek to understand, at a molecular level, a novel mechanism by which these receptors signal to the inside of cells, laying the basis for next-generation therapeutics for cardiovascular and other diseases.